The VETSA Longitudinal MRI Twin Study of Aging (VETSA MRI 4)

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is costly and burdensome. As the US population ages, AD’s public health impact
continues to grow. NIH and Alzheimer’s Association consensus statements indicate that understanding early
phases of disease progression—such as mild cognitive impairment (MCI)—beginning in middle age is key to
slowing dementia onset. Identifying at-risk individuals early is also estimated to result in massive savings.
Despite the protracted progression of AD brain pathology, little is known about its temporal course from middle
to older age, particularly for neuroimaging indices. The Vietnam Era Twin Study of Aging (VETSA) focuses on
early identification of risk for MCI/AD and AD-related brain changes beginning when subjects were in their 50s.
The proposed VETSA MRI wave 4 project, with a mean age of 74 (67-78), occurs during a time of increased
incident MCI/AD. That, in combination with our longitudinal data, allows for improved ability to determine
neuroimaging correlates, trajectories, and their predictors. Continued data collection will allow us to examine
the transition period from pre- to post-disease onset and expand on prediction from midlife for an increasing
number of individuals. This project is linked to the funded general VETSA 4 grant (AG050595) which collects
10-12 hours per subject of cognitive, health/medical, psychosocial and biomarker data. In addition, we can
elucidate genetic and environmental influences on these processes via combined twin and genome-wide
genotyping/polygenic score data. We also capitalize on early (age 20) cognitive data, a unique feature
enabling us to differentiate cognitive decline from longstanding differences. We request funds to cover MRI
acquisition, processing, and analysis (n=500), leveraging associated ongoing work in the general VETSA 4
grant. Aims are: 1) Develop, validate, and characterize novel early brain indicators of risk for MCI/AD. We will
develop and validate a novel AD brain signature based on diffusion MRI and show that this brain signature of
adults who are only in their 50s improves prediction of progression to MCI. We also hypothesize that integrity
of the locus coeruleus—the earliest brain site of tau deposition—will be another early, sensitive risk indicator.
2) Examine cerebrovascular risk factors and their relationship with cognition and AD biomarkers.
Cerebrovascular disease (CVD) is the most common pathology concomitant with AD and may contribute to
disease progression or be an independent source of brain and cognitive decline. We particularly focus on CVD
markers of white matter hyperintensities and arterial spin labeling (ASL) perfusion. 3) Quantify the magnitude
of neurodegeneration from midlife to early old age and its underlying genetic and environmental influences.
We will examine genetic influences on longitudinal change in macro- and micro-structural brain measures. Our
approach includes identifying mediating/moderating effects of risk factors across the lifespan and leveraging
our twin and genome-wide genotype data. Covering ~18 years, this project will be a resource for advancing
knowledge about early identification of risk for MCI/AD, with potential for a profound public health impact.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is considered the most costly and burdensome disease in the U.S, and its public health impact will only grow with the increase of older adults in the next decade. Despite the protracted progression of AD brain pathology, little is known about its early temporal course from middle to older age, particularly for in vivo neuroimaging indices. With neuroimaging, cognitive, and biomarker data beginning when participants were in their 50s, the longitudinal VETSA MRI project stands to advance progress toward early identification, and in turn, toward improving quality of life and reducing societal burden.